Evaluating the Feasibility of Force-Based and Position-Based Prosthetic Control for Children Born without a Hand

Project Summary/Abstract
Congenital upper limb deficiencies are the most common reason for limb absence in children and occur in
approximately 1 in 500 live births. Although many children are prescribed a prosthetic arm to offset functional
deficits, abandonment rates among pediatric users range as high as 45%, nearly double the rate of adult
abandonment. A main driving factor for this is that highly functional adult prosthetic control systems—namely
pattern recognition and machine learning methods—have not yet been translated to children due to a belief that
they may not have the control over their residual muscles required to use such systems. Our research says
otherwise, finding that 9 children born without a hand were successfully able to imagine moving their affected
muscles into 10 unique grasps, and resulting in highly classifiable data. Therefore, my long-term research goals
are to (1) define the innate capabilities of children born with upper limb deficiencies and (2) leverage those innate
abilities to help develop more dexterous pediatric prosthetic devices. I will work towards these goals by fusing
two existing prosthetic control systems: the long-established surface electromyography (sEMG), which measures
the electrical activity of the muscles, and the recent advancement of sonomyography (ultrasound, US), which
images the muscle deformation within the arm. Individually, our work has shown that these systems, in
conjunction with machine learning algorithms, can predict missing hand grasp intent with accuracies of 70-99%,
but they have never been used together. It remains unknown the degree to which their complementary
information can be used to exceed what each system can achieve individually, and thus offer more advanced
control techniques such as proportional force or proportional position control. I will pursue the following specific
aims: (1) Maximize the combined static state prediction accuracy of sEMG and US using a naïve Bayesian fusion
approach, and (2) Investigate the feasibility of pediatric proportional control by building regression models to
predict a spectrum of desired grasp force and position values. My central hypothesis is that children will have
a considerable level of proportional control over their residual muscles, reflected in high classification accuracies
and low regression errors, and that fusing sEMG and US will result in significantly higher classification accuracies
than either system can achieve in isolation, indicating a high level of complementary function. By the end of this
proposal, we will have a much richer understanding of children’s innate control and the nuanced information
encoded in their affected muscle activity. This will result in better classification of motor intent for prosthetic
control and establish the feasibility of incorporating advanced, proportional control techniques into pediatric
prosthetic limbs. We will also have built the first dataset that examines the ability of children to modulate both
intended force and position, and that records time-synchronized data of sEMG and US working together. This
proposal will serve as the foundation on which highly functional, pediatric prostheses can be designed.

Public health relevance
Project Narrative Children born with upper-limb deficiencies have high rates of prosthetic abandonment due to a lack of functional, intuitive devices catered towards their demographic. By fusing two established prosthetic control systems, we can define the level of muscular control in these children. We can then leverage this understanding to develop a new model for pediatric prostheses that provides not only more accurate grasp classification, but also the possibility of proportional force and position control.